Administrative Core

Administrative – Project Summary
The Administrative Core Module provides the overall supervision and management of Penn’s Core Grant for
Vision Research. This will be accomplished under the leadership of the PI, Dr. Brainard. Dr. Brainard is
assisted by an Executive Committee consisting of the core module directors and other senior vision
investigators at Penn. The Executive Committee has two primary administrative functions. The first is to
monitor the projects of the core grant scientific staff, and provide direction and coordination with respect to
these projects. As part of this, the Executive Committee collectively is aware of the full scope of vision research
at Penn as well as the projects being supported by the core modules, and is alert to the possibility of identifying
opportunities for collaboration between Penn vision investigators. The second EC function is to oversee the
management of the core grant itself. In addition, staff support is provided through the Administrative Core
Module for managing budgets, scheduling events, and preparing reports. Although disputes are not expected,
formal procedures are provided for resolving any such disputes.